Relationships Between Pain-Related Psychological Factors, Gait Quality, and Attention in Chronic Low Back Pain

Project Summary/Abstract
Poor gait quality in chronic low back pain (cLBP) contributes to decreased mobility and functional decline. Those
with cLBP and pain-related psychological factors (e.g., fear-avoidance, pain catastrophizing) are at elevated risk
for these poor clinical outcomes. However, the relationships between fear-avoidance/pain catastrophizing and
gait quality in cLBP remain unknown, largely due to use of inconsistent gait quality metrics in small samples. To
improve clinical outcomes in this at-risk population, there is a critical need to 1) examine relationships between
fear-avoidance/pain catastrophizing and gait quality using rigorous metrics, and 2) conduct a mechanistic
exploration of contributors to gait quality impairments. As a first step toward the long-term goal of improving
physical therapy interventions for cLBP, the overall objective of this proposal is to 1) determine the relationship
between fear-avoidance/pain catastrophizing and gait quality, and 2) test the contribution of attention on gait
quality in those with heightened fear-avoidance/pain catastrophizing. The rationale is that establishing the ways
in which fear-avoidance/pain catastrophizing are related to gait quality may lead to new treatment interventions
(e.g., cognitive reframing surrounding movement, attention-shifting strategies) to improve clinical outcomes in
this high-risk population. The central hypothesis is that 1) fear-avoidance/pain catastrophizing is associated with
worse gait quality, and 2) reduced attention capacity associated with fear/catastrophizing contributes to poor gait
quality. Aim 1 is to determine the relationship between fear-avoidance/pain catastrophizing and gait quality in
cLBP. Aim 2 is to determine the role of attention in the relationship between fear-avoidance/pain catastrophizing
and gait quality. Under Aim 1, accelerometry-based gait quality metrics will be derived from a large, existing raw
data set (n=500) collected as part of an ongoing grant (1U19AR076725-01). For Aim 2, 50 participants will be
recruited to perform a dual-task assessing the impact of attention on gait quality. The proposed project is
significant because it uses rigorous, accelerometry-based metrics to examine relationships between fear-
avoidance/pain catastrophizing and gait quality, and it is the first and necessary step toward identification of
novel treatment targets (i.e., fear, attention-related deficits) that when prioritized in physical therapy, may improve
outcomes in this population. Under this fellowship, the applicant will gain unique opportunities for integration of
top-tier research and clinical training through University of Pittsburgh’s DPT/PhD in Bioengineering program.
The proposed project will be completed within the University of Pittsburgh NIH-funded BACPAC Consortium
Mechanistic Research Center, where the trainee will have unrivaled access to experts across the country,
recruitment and biostatistical support, and novel infrastructure to advance her toward a career as an independent
clinician-scientist. A mentorship team consisting of experts in chronic low back pain, gait, attention, translational
research, and pain psychology will support the applicant’s training goals in research methods/design, gait
accelerometry, human movement, professional development, and mentorship.

Public health relevance
Project Narrative The proposed research is relevant to public health because it represents a novel exploration of gait quality impairments in a chronic low back pain population with heightened fear-avoidance/pain catastrophizing, which puts them at increased risk for poor clinical outcomes. Identification of gait quality impairments in this high-risk population may lead to improved physical therapy interventions. Thus, the proposed research is relevant to the NIH’s mission to enhance health and reduce illness and disability.